Feedback mechanisms link tubulin PTMs to Golgi organization

Project Summary/Abstract
Regulation of the microtubule cytoskeleton is essential for critical cellular processes at all stages of life.
Microtubules are dynamic filaments generated by polymerization of the protein tubulin, one of the most
conserved proteins across the eukaryotic kingdom. Microtubule functions are determined by the Tubulin Code
which posits that, in cells, specific microtubules are distinguished biochemically by post-translational
modifications (PTMs) of tubulin that determine specific functional outputs. An important PTM for microtubule
function during intracellular trafficking and cell migration is detyrosination in which the C-terminal tyrosine of a-
tubulin is enzymatically removed. The mechanisms by which specific subsets of microtubules are selected for
modification is a major knowledge gap in the field. The overarching goal of this proposal is to define the
mechanisms by which individual microtubules are identified and chosen in cells for specific microtubule post-
translational modifications. I will utilize biochemical and cell biology-based approaches to determine how cells
utilize mechanical cues to drive microtubule PTMs and how these cues may be altered to drive aberrant cell
processes including enhanced polarized secretion and cell migration. Combined, this work will greatly advance
the dynamic and emerging knowledge in the field of how cells utilize writers and readers of the Tubulin Code to
modify microtubule tracks and promote cell migration in normal and disease contexts.

Public health relevance
Project Narrative Precise regulation of the microtubule cytoskeleton is essential for critical cell processes including intracellular trafficking, cell motility, and cell division. We will utilize biochemical and cell-based approaches to gain novel insights into how cells spatially and temporally regulate microtubule post-translation modifications to promote or inhibit cell processes including secretion and migration. These studies will provide critical insights into how different cell types write their Tubulin Code and will thus impact diverse fields, including neurobiology, cardiac function, and cancer research.